UIC Animal Facility Environmental Monitoring System

Project Summary
The enclosed application seeks to enhance the animal housing facilities at the University of Illinois Chicago
(UIC). UIC's animal care and use program consists of eight centrally managed animal facilities totaling
approximately 135,000 sq. ft. of animal housing and support space. The facilities support the research efforts of
approximately 300 investigators and covers housing and husbandry of approximately 40,000 animals. The
program is supported by a staff of ACLAM board certified veterinarians, post-doctoral fellows in laboratory animal
medicine, certified veterinary technicians, and a strong animal care staff. Towards our efforts to modernize
university research facilities, we are seeking to add environmental monitoring to the Biological Resources
Laboratory (the institution's centralized animal facility) as well as 7 other centrally managed animal facilities at
UIC. Specifically, we will purchase and install a Rees Scientific environmental monitoring system in the UIC
animal facilities. The requested wired and wireless monitoring will provide temperature, humidity, and light
monitoring. Real-time 24/7 monitoring of animal room temperatures requires a robust environmental monitoring
system capable of not only identifying when temperatures fall out of an acceptable range but also capable of
notifying multiple response team members through a variety of communication methods, such as phone, text or
email. Once in place and operational the Rees Scientific environmental monitoring system will monitor in real-
time 24/7 common extrinsic factors known to affect animal research including temperature, humidity, and light. In
addition, the system will track pressure differentials in select bio and chemical hazard rooms. In all cases the
system will notify animal care, research and facilities management staff when parameters fall outside the
designated range for an animal species, research model and/or functional room use. In summary, this project
will address a fundamental need in improved animal husbandry, minimize variables and facilitate state of the art
biomedical research.

Public health relevance
Project Narrative The University of Illinois Chicago (UIC) has a robust animal-based research program that supports over $110 million in biomedical research and an average daily census of approximately 40,000 animals. UIC proposes to modernize its centrally managed animal facilities by purchasing and installing a cloud-based environmental monitoring system that will improve animal well-being, safety, regulatory compliance, and ensure experimental reproducibility while also resulting in significant efficiencies in operational management. Such an upgrade will directly improve the institution's animal facility infrastructure to facilitate both biomedical research discoveries and research reproducibility.